Heavy cannabis use, neurocognition and PrEP care engagement among young Black sexual minority men

We propose to conduct research that will determine the impact of relevant behaviors on HIV prevention among young people, such as heavy cannabis use. Data from our group and others demonstrate heavy cannabis use as prevalent and increasing in young people is associated with HIV acquisition, use as a sex-drug, greater likelihood of membership in an HIV transmission cluster, and decreased HIV testing. We propose to explore mechanisms, specifically neurocognitive impacts of heavy cannabis use, linking heavy cannabis use to HIV prevention outcomes, and whether motivations for cannabis use, amidst a changing cannabis regulatory, social acceptance and legal landscape, modify its effects on HIV prevention. In the proposed study, we will rigorously examine links between heavy cannabis use, neurocognition, sex behavior and PrEP care engagement. First, we will elucidate the effects of cannabis use on neurocognition - specifically, brain systems supporting risk/reward (RR) processing, as well as higher order organizational functions collectively referred to as executive function (EF) in young people. Second, we will explore how cannabis use, directly and via neurocognitive impacts, is associated with HIV prevention, and particularly PrEP care engagement (primary outcome). The proposed study will integrate and expand these lines of research within the context of traditional health department and CDC supported HIV prevention programs that engage young people in the South Side of Chicago and adjacent suburbs. We will use rigorous objective measures to assess cannabis use (e.g., quantification of cannabis metabolites in plasma), neurocognition (e.g., neuroimaging) and PrEP outcomes (e.g., EMR measured persistence), and triangulate that data using validated survey measures. We will also rigorously account for other substance use, as a proportion of young people who use cannabis also use other substances (e.g., alcohol), and there is increasing recognition of the need to study substance use as it occurs in real-world settings, including polysubstance use. We will assess these factors longitudinally over 1.5 years (3 times 9 months apart) in a cohort of 280 young people living with and living without HIV, to permit examination of within-individual biological changes and the dynamic nature of cannabis use and its association with prevention care outcomes.
We propose to conduct research that will determine the impact of relevant behaviors on HIV prevention among young people, such as heavy cannabis use. We propose to explore mechanisms, specifically neurocognitive impacts of heavy cannabis use, linking heavy cannabis use to HIV prevention outcomes (and particularly PrEP use), and whether motivations for cannabis use, amidst a changing cannabis regulatory, social acceptance and legal landscape, modify its effects on HIV prevention. Identifying neurocognitive mechanisms through which cannabis use affects HIV prevention and the importance of motivations for cannabis use in understanding clinical outcomes will provide targets for future HIV prevention efforts.

Public health relevance
PrEP is critical to curbing the HIV epidemic in young people, yet remains severely underutilized. Heavy cannabis use is highly prevalent in young people, yet much remains unknown about how it impacts neurocognition and HIV prevention. We will rigorously characterize cannabis use and assess its contribution to PrEP, directly and via its neurocognitive impacts. Given the high prevalence of cannabis use and its increase amidst growing legalization, this study has promise for significant public health impact, and will lead directly to the development of interventions that address cannabis use, neurocognition and HIV prevention among young people. 2